Engineering Modular Oxygen-generating, Pro-vasculogenic Biomaterial Platforms for Cell-Based Therapies

PROJECT SUMMARY/ABSTRACT
In this proposal, we aim to develop two distinct biomaterial systems for improving nutrient and oxygen
availability within cell-based clinical islet transplantation (CIT) platforms for the treatment of type 1
diabetes mellitus (T1DM). The motivation for this work is the lack of durable systems for oxygen
supplementation of transplanted, insulin-producing cells, as well as the limited optimization of scaffolds for
facilitating competent and complete implant vascularization.
T1DM affects over 1.25 million Americans and is expected to quadruple by 2050. Previous attempts to treat
T1DM through the transplantation of islets is limited due to hypoxic conditions and delayed graft vascularization.
Published and preliminary data from our laboratory has demonstrated that the inclusion of a biocompatible,
oxygen-generating composite material, termed OxySite, alongside transplanted insulin-producing cells can lead
to prolonged cell survival and insulin production post-transplantation. By delivering local oxygen immediately
post-transplantation, this approach should bridge the gap between initial transplant and the establishment of
competent vascularization. Herein, we seek to manipulate the geometry and material properties of the original
OxySite prototypes to enhance geometric flexibility and oxygen kinetic control. In addition, it is recognized that
traditional vascularization techniques fail to provide timely support for cells at the site of transplant due to the
prolonged process for endogenous cell infiltration and organization into cell-based grafts. Herein, we seek to
identify an optimal geometry for guiding vascularization. Overall, we hypothesize that through engineering a
modular oxygen-generating microbead platform to fit multiple transplant sites and release requirements, in
conjunction with a flexible scaffolding that utilizes geometry and pore size to accelerate the process of
vascularization, transplanted cells can be supported at all time periods post transplantation.
Fabrication and implementation of these two platforms would provide a significant improvement to CIT
applications, as well as other cell-based therapies. Furthermore, we anticipate they will also give valuable insight
into the design of materials for controlled therapeutic release and into the mechanisms of vascularization. Our
laboratory has previously used biomaterials to not only improve CIT platforms but also reveal crucial relationships
involved in cell engraftment and long-term function. The techniques outlined in these previous studies will serve
as a starting point for the proposed work. In Aim 1, we will explore whether generating porosity, modulating
OxySite material formulation, and applying a rate limiting polymer can permit fabrication of a modular, oxygen-
generation platform. We will further characterize this new platform utilizing a model islet transplantation platform.
For Aim 2, we will design and fabricate a flexible, scaffolding using 3D printing to allow for configurable pore size
and geometry. We will use an in vitro pre-vascularization method for rapid testing of varying pore sizes for optimal
vasculature formation before proceeding to a subcutaneous biocompatibility model.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes mellitus (T1DM) affects over 1.25 million Americans and the current lack of a sustainable treatment that provide physiological regulation of an individual’s blood glucose results in increased morbidity and poorer quality of life for affected individuals. While cell-based therapy has the inherent capacity to provide intimate glucose regulation, cell survival is poor due to the impaired oxygen and nutrient delivery to these implants. In this proposal, we seek to engineer and implement two complementary systems to address this need: an oxygen-generating microbead platform with tailored kinetics and a vascular guiding scaffolding for durable and complete vascularization. The ultimate goal of this proposal is to eliminate these major roadblocks to cellular treatments for T1DM, while also development platforms translatable to other cell-based therapies.